The Dopamine Synapse and Associative Learning

Project Summary/Abstract
Dopamine (DA) neurotransmission in the dorsal striatum and nucleus accumbens has been implicated in drug
seeking and reward since the 1950s, when it was shown to mediate the effects of cocaine and opiates. However,
our and other’s recent work has shown that DA also plays a role in another circuitry critical for drug dependence.
Within the rostral striatum (tail of the striatum: TS) – the central locus where auditory DA, cortical and thalamic
axons converge to control auditory learning – DA neurotransmission is necessary for learned association of a
sound with a behavior, such as drug self-administration. To address this role for DA, we have developed novel
technical approaches that allow us to measure activity and neuronal signaling during associative learning and
recall tests, and then to correlate changes in animal behavior and in vivo synaptic activity with detailed ex vivo
analysis after learning. These experiments have led to the identification of a new form of synaptic plasticity that
occurs at auditory thalamic inputs to the TS projection neurons, consisting of a simultaneous decrease in overall
activity with a concurrent increase in response to a specific sound cue. This form of enhanced signal-to-noise
response by specific synapses may provide a basis of sensory cue learning. This project tests i) the precise
physiological and molecular steps required for auditory sensory learning; ii) the role played by the TS dopamine
and glutamate neurotransmission in this form of learning and synaptic plasticity, and iii) a role of DA in “refining”
TS synaptic circuits in order to allow further learning. These experiments promise to unveil the molecular steps
responsible for the action of addictive drugs such as amphetamine and opiates that drive self-administration,
and will further be important for understanding language disorders, hallucinations and affective disorders
including ADHD and PTSD.

Public health relevance
Project Narrative The dopamine system has been widely studied to elucidate the reinforcing properties of substance abuse, but far less is known on how this system regulates how cues, for example, drug-associated words or environments, act to trigger drug self-administration. Our research investigates how these cues become associated with outcomes and meaning, which appears to require dopamine-dependent changes in specific synaptic connections between auditory inputs to neurons that control decision making. This project explores how these learning-dependent changes occur in the brain, and the results are expected to contribute to understanding the brain mechanisms driving substance abuse, as well as symptoms of disorders including hallucinations in psychosis, attention deficit, post-traumatic stress disorder and deficits in language learning in neurodevelopmental disorders including autism.